Cell type-specific regulation of cortical development by the autism risk gene Foxp1

Project summary/abstract
Autism spectrum disorders (ASD) are estimated to affect 1 in 36 children in the US, yet treatments for ASD remain
limited. Mutations in the transcription factor, FOXP1, have been linked to ASD, yet the precise role for Foxp1 in either
neurodevelopment or ASD remains incomplete. Previous studies of ASD have also shown that the cortex may exhibit
disrupted structure and function. In line with this, we previously created a forebrain specific Foxp1 knockout mouse model
and observed that there were behavioral abnormalities including social deficits, communication impairments, and
hyperactivity. However, the molecular mechanisms that result from Foxp1 loss in early neocortical development remain
unclear. Given the cell-type specific expression pattern of Foxp1 during cortical development, understanding the cell
specific function of Foxp1 is critical for the advancement of our understanding of neurodevelopmental disorders. Here, I
propose to evaluate the impact of Foxp1 loss on two aspects of early neocortical development: migration and cell fate.
First, I hypothesize that Foxp1 loss disrupts radial migration of upper layer neuronal subtypes through their
interaction with aRGC fibers. I will test this hypothesis by utilizing 1) BrdU birth dating to track migration of neurons from
the VZ along with 2) GFAP staining of aRGC fibers and 3) MERSCOPE’s capacity for detecting up to 1000 cell-type
markers at a single time to determine the cell-type specific impact of Foxp1 loss on neuronal migration during upper and
lower layer cortical neurogenesis. Concurrently with this, I will also stain for genes identified as downstream targets of
Foxp1 through the collection of snRNAseq and CUT&RUN data in order to determine the impact of Foxp1’s downstream
targets on migration.
Secondly, I hypothesize that Foxp1 loss disrupts the timeline of neurogenesis causing changes in neuronal cell fate.
In Aim 2, I will test this hypothesis by leveraging data from Aim 1 to assess the impact of Foxp1 on cell-type and cell fate
during canonical upper layer and lower layer neurogenesis. I will do this by comparing the birthtime of a neuron, indicated
by BrdU, to its cell-fate after two or after seven days. I will also repeat experiments from Aim 1 during the proliferative
and gliogenesis phases of cortical development to determine whether cell fate is altered.
By completing these aims and receiving training in the methods needed to generate and analyze these data, I will
determine which cell types are most vulnerable to migration and cell fate deficits in a model system relevant to ASD. I will
also provide key insights into the mechanisms of neurodevelopment, migration, and cell fate in the developing embryonic
cortex. This will ultimately provide a critical foundation for the advancement of precise cell type targeted genetic therapies
of neurodevelopmental disorders. Furthermore, I will receive training in cutting edge wet bench technologies, including
cellular resolution spatial transcriptomics, CUT&RUN, and snRNAseq while gaining tremendous experience as a
bioinformatician. This expertise will enable me to continue to advance our understanding of cell type-specific genetic
contributions to development and disease throughout my career.

Public health relevance
Project narrative FOXP1 is important for early brain development and has been linked to a number of neurodevelopmental disorders. Here, I will discover the function of FOXP1 in the developing brain at a cell type level using genomic approaches. I will receive training in both experimental and computational methods and apply this knowledge to advance my career and make contributions to understanding brain development and disease.